Blood and Marrow Transplant Clinical Trials Network DCC- The Medical College of Wisconsin, Inc.

PROJECT SUMMARY/ABSTRACT
Hematopoietic cell transplantation (HCT) and adoptive cellular therapy (ACT) offer curative treatment for di-
verse malignant and non-malignant diseases. This field is rapidly developing new strategies for patient assess-
ment, cell selection and manipulation, and pre- and post-procedure treatment. New prophylactic and therapeu-
tic modalities require evaluation in definitive clinical trials, as does the role of HCT versus other therapies.
HCT/ACT trials face unique challenges, including the small number of procedures done at each center, the di-
verse indications for treatment requiring dissimilar approaches, the complexity of the interventions, the multi-
ple, competing risks in the early post-treatment period, and important, though infrequent, late effects. The
Blood and Marrow Transplant Clinical Trials Network (BMT CTN) was established in 2001 to perform scientifi-
cally meritorious, prospective clinical trials to address these issues. The Network has launched 62 trials with
the support of a Data Coordinating Center (DCC) formed through a consortium of organizations with synergis-
tic expertise: the Medical College of Wisconsin (MCW), the National Marrow Donor Program (NMDP), and The
Emmes Company. This unique Consortium leverages the critically important real-world database of the Center
for International Blood and Marrow Transplant Research (CIBMTR), jointly operated by MCW and NMDP. The
DCC consortium proposes to continue supporting the Network and use its expertise to provide efficient devel-
opment, implementation, and completion of high-quality clinical trials, including concept evaluation and prioriti-
zation; protocol development with appropriate and innovative statistical designs; timely activation and accrual;
monitoring for safety, compliance, and data accuracy; and analyzing and disseminating results. The DCC con-
sortium will coordinate and support all BMT CTN activities by: maintaining a state-of-the-art, secure database
and systems for acquisition and storage of biospecimens, including development of a repository of longitudinal,
clinically annotated specimens from a diverse cross-section of patients receiving cell and gene therapies for
non-malignant blood diseases; ensuring data quality, laboratory compliance, and adherence to regulatory re-
quirements; managing contractual arrangements and fiscal activities; monitoring and improving center and
overall Network performance; supporting logistics for Network Committees and activities; enhancing access to
trials for all patients regardless of ancestry, demographics or socioeconomics; and fostering the next genera-
tion of researchers from diverse backgrounds by providing didactics, mentorship, and meaningful career-en-
hancing experiences. The DCC will continue to leverage Network resources and expertise by collaborating with
the National Cancer Institute-funded National Clinical Trials Network Groups, CIBMTR’s Working Committees,
industry partners, and advocacy groups. These collaborations will maximize completion of scientifically rigor-
ous, clinically relevant, innovative HCT/ACT clinical trials, especially for non-malignant blood disorders and
with novel cell/gene therapies, including those that require collaboration with non-HCT/ACT investigators.

Public health relevance
PROJECT NARRATIVE The proposed Data Coordinating Center (DCC) will support all activities of the Blood and Marrow Transplant Clinical Trials Network, using the extensive expertise of its investigators in clinical and translational research, biostatistics, transplantation, and cellular therapies. The DCC will take advantage of collaborations with other organizations and initiatives to maximize efficiency and trial participation. The goal is to facilitate trials that pro- vide definitive answers to important clinical questions that will lead to changes in practice that increase survival and enhance quality of life for patients with serious malignant and non-malignant blood diseases.